University of Rochester Intellectual and Developmental Disabilities Research Center

Project Summary: The University of Rochester’s Golisano IDDRC fosters innovative and collaborative
research efforts among multidisciplinary investigators. The center's primary goals include advancing basic and
translational science to understand the causes and consequences of intellectual and developmental disabilities
(IDDs), sustaining essential research infrastructure, building interactive research teams, attracting and training
new investigators, fostering communication and collaboration, and promoting community outreach and
education. The Golisano IDDRC operates through four scientific cores: Human Phenotyping and Recruitment
(HPR), Translational Neuroimaging & Neurophysiology (TNN), Cell and Molecular Imaging (CMI), and Animal
Behavior and Neurophysiology (ABN).
The center also focuses on specific research clusters, including rare neurodevelopmental diseases,
parental stress and early life exposure, neuroinflammatory mechanisms, autism spectrum disorder, and
multisensory integration. The center's efforts are supported by an annual fund for IDD pilot projects and a
commitment to evaluating progress and maximizing impact. Our objective is to leverage institutional resources
and areas of expertise to optimize the efficiency, innovation, and quality of research to improve the lives of
patients and families with IDD.

Public health relevance
Modified Public Health Relevance Section Project Narrative: This new University of Rochester IDDRC establishes the essential scientific Core infrastructure and administrative architecture to cohere the exceptional talents of 105 IDD investigators around five highly interlinked research cluster thematic foci and articulates a clear purpose for our coordinated efforts – to serve persons with IDD to the best of our abilities, placing their interests at the heart of our research enterprise. Through a concerted effort across basic, translational and clinical investigators, we have set ourselves the clear goal of providing actionable clinical solutions for our IDD community. We will partner with our IDD community to communicate our work, and our passion, in a manner that is culturally competent, and publicly oriented.